Leveraging Hyperpolarized MRI for Precision Oncology Approaches in Head and Neck Cancer

PROJECT SUMMARY/ABSTRACT
Head and neck squamous cell carcinoma (HNSCC) remains a leading cause of cancer deaths worldwide.
Genotoxic agents, including radiation therapy (RT) and cisplatin (CDDP), are treatments that damage cellular
DNA. RT and CDDP are the current standard of care in multiple solid tumors, including HNSCC. CDDP is the
most commonly used chemotherapeutic agent in HNSCC proving superior to novel targeted agents in recent
large randomized trials. Despite this, high rates of treatment failure persist in patients who develop resistance
following this toxic chemotherapy. Treatment failure is uniformly fatal. However, no robust predictors of
acquired cisplatin resistance or tumor response exist. Given this critical unmet need, we have focused our efforts
on the assessment of tumor response using minimally invasive quantitative imaging (hyperpolarized magnetic
resonance imaging; HP-MRI) while patients are undergoing therapy. We showed that CDDP and other genotoxic
agents trigger measurable fluctuations in tumor cell metabolism detectable through HP-MRI with [1-13C]-pyruvate
in real time (confirmed by conventional biochemical assays). Genotoxic stress suppresses the apparent rate of
pyruvate conversion into lactate (kPL) via lactate dehydrogenase (LDH) in a manner that correlates with anti-
tumor effectiveness. We therefore hypothesize that changes in kPL provide unique insight into metabolic
changes induced by cisplatin that can be used to optimize response to therapy in HNSCC.
In Aim 1, we will characterize baseline HP-MRI parameters such as kPL across the spectrum of HNSCC
subtypes and validate the relationship between CDDP and associated shifts in carbon flux. We will also identify
metabolomic differences in HNSCC models that affect baseline values of metabolic imaging biomarkers and
modulate apparent changes induced by cisplatin. In Aim 2, we will integrate the dose-response data from Aim 1
to develop a predictive model of response to CDDP based on metabolic imaging parameters. We will use a
simple algorithm to adjust therapeutic dose based on HP-MRI data in animal models of HNSCC to maximize
tumor growth delay, and test whether thresholds suggestive of strong response can be used to select the more
effective treatment regimen when multiple regimens are tested in parallel. In Aim 3, we will conduct a first-in-
human evaluation of changes in HP-MRI to detect shifts in carbon flux following CDDP in HNSCC patients. We
will correlate changes in metabolic imaging parameters with the baseline metabolic phenotype of tumors as
determined from metabolomic analysis and direct measurements of tumor LDH. Successful completion of this
study will establish HP-MRI as a non-invasive imaging modality able to predict response to treatment,
which will be a noteworthy first step towards a precision oncology approach that we have been seeking for nearly
half a century. Thus, the proposed research is relevant to the part of the NIH’s mission that pertains to developing
and applying fundamental knowledge that will help to reduce the burdens of human illness and addresses directly
the recently published “Notice of Special Interest: Precision Imaging of Oral Lesions” (NOT-DE-21-010).

Public health relevance
NARRATIVE The proposed translational research will use real-time metabolic imaging (hyperpolarized MRI) to assess tumor response to genotoxic stress induced by cisplatin in head and neck squamous cell carcinoma (HSNCC). The work is relevant to public health because this approach will provide a basis for adaptive changes to maximize treatment effectiveness and personalize the management of not only HNSCC, but also other solid tumors. As genotoxic agents remain the mainstay treatment for most solid tumors, this will be a true first step towards a precision oncology approach that we have been seeking for nearly half a century.